Administrative Core

Abstract – Administrative Core
The Administrative Core of the Scalable TELeheaLth cancer cARe (STELLAR) Center on Telehealth Research
will provide the overall organizational and administrative oversight and management of Center activities. This
will include developing and applying a cohesive operational framework as well as overseeing the fiscal
management, evaluation, communication, and dissemination activities of the Center (including the Research
and Methods Core, Rapid Cycle Pilot Studies, Clinical Practice Network, and Pragmatic Trial). The
Administrative Core will facilitate STELLAR communications within and beyond the Center (e.g., via a website,
e-newsletter, and annual retreats). It will create and employ policies and procedures for the organizational
structure, leadership, ethical conduct, and clinical trials oversight of all Center activities. The Administrative
Core will develop and implement methods and processes for monitoring the fiscal, scientific, and dissemination
progress, timelines and milestones of all Center components and activities. It will establish and convene an
External Advisory Board, Internal Advisory Board, Community Advisory Board, and Policy Advisory Group of
key stakeholders who will help guide the Center’s work by identifying strategies that optimize telehealth
delivery, maximize the external validity of research findings, and support dissemination of project findings and
resources. The Administrative Core will be comprised of five components created to direct work integral to
Center goals, the: Steering Committee; Operations Team, Evaluation Center, Equity Working Group, and
Dissemination and Education Committee. The latter will lead efforts to promote opportunities for trainees and
early-stage investigators to participate across Center components and activities. The Administrative Core’s
aims are to (1): provide management, coordination and evaluation of STELLAR components and activities
within a cohesive organizational infrastructure; (2) facilitate and oversee communication and engagement
across the Center in order to enhance the research capacity of the proposed studies and sustainability of
clinical tools and programs; and (3) accelerate dissemination of project processes, tools, and findings (locally
and nationally) in order to advance a robust evidence base for fully integrated, telehealth-based
comprehensive cancer care. Efforts will emphasize synergistic collaborations of transdisciplinary teams toward
STELLAR’s overarching goal to optimize comprehensive and accessible cancer care by leveraging telehealth
delivery and emphasizing cancer risk behavior treatment services.